Mechanistic Studies on the Impact of Sleep Deprivation on Gene Regulation

Project Summary
Sleep deprivation presents an increasing threat to individual health and public safety as well as an economic
burden due to lost productivity, traffic accidents, occupational accidents, and skyrocketing healthcare costs.
There has been an astonishing rise in the number of individuals affected by sleep deprivation with
approximately 35% of U.S. adults and a staggering 70% of teenagers reporting insufficient sleep. Sleep
deprivation induces significant impairments in memory and performance, aggravates psychiatric and
neurological disorders and increases disease risk, especially neurodegenerative disorders such as Alzheimer’s
disease. Given the significant number of people affected by sleep deprivation, and the potentially devastating
consequences of sleep loss in terms of disease and dementia, it is essential to identify the cellular
consequences of sleep deprivation and to define the specific molecular targets and processes impacted.
Recent research suggests that the influence of acute sleep deprivation on memory occurs at the cellular and
synaptic level, although the specific mechanisms through which sleep deprivation exerts these effects remain
poorly understood. The hippocampus, a critical brain region for memory, is particularly susceptible to the
effects of acute sleep deprivation. Previously, we found that sleep deprivation decreases protein synthesis in
the hippocampus leading to impairments and deficits in synaptic plasticity. We hypothesize that sleep
deprivation targets multiple processes that affect the regulation of gene expression, which is comprised of
changes in transcription, RNA processing and localization, and protein synthesis. The objectives of this
proposal are to define the molecular and cellular mechanisms through which sleep deprivation impacts gene
regulation and to define the affected subregions and cell types within the hippocampus. In Specific Aim 1, we
focus on the signaling pathways through which sleep deprivation affects protein synthesis to adversely impact
long-term memory and synaptic plasticity with a focus on identifying mechanisms of resilience to sleep loss. In
Specific Aim 2, we investigate the effects of sleep deprivation on RNA fate at the subcellular level and
explicitly detail the effects of sleep deprivation on the pool of mRNA available for translation. In Specific Aim
3, we employ state of the art techniques to define the impact of sleep deprivation across subregions within the
hippocampus and within individual cell types providing a detailed spatial map and cellular signature of the
effects of sleep deprivation. The results from our comprehensive proposal integrating in vivo behavioral
manipulations to mitigate the effects of sleep deprivation on memory, the subcellular analysis of the effects of
sleep deprivation on RNA fate and protein synthesis, and the identification of cell specific signatures of sleep
deprivation, will provide significant insights into the negative impacts of sleep deprivation on memory,
potentially leading to the development of therapeutics to counteract the consequences of sleep loss on
cognition and neurodegenerative disorders.

Public health relevance
Project Narrative Sleep deprivation is a rapidly growing public health concern impacting millions of Americans and causing significant impairments in memory and cognitive performance, impairments that have been shown to aggravate numerous psychiatric and neurological disorders, including neurodegenerative diseases such as Alzheimer’s disease. In the proposed research, we investigate the molecular and cellular mechanisms impacted by sleep deprivation to identify specific molecular targets affected by sleep deprivation, define specific regions affected within the hippocampus and define the cellular signature of acute sleep deprivation at the single cell level. The results from the proposed research will provide a critical base for the future development of novel therapeutics to alleviate cognitive impairments associated with sleep loss.